CONTROL OF RENIN SECRETION

This research concerns the coupling role played by calcium in the secretion of renin from the kidney. Rat renal cortical slices are used. Transmembrane Na gradient, via operation of a putative Na-Ca exchange mechanism, affects intracellular Ca (Cai). Na gradient is reduced by increases in Nai (achieved by inhibition of Na, K-ATPase using low Ke, ouaban or vanadate) or decreases in effects on renin secretion. Na gradient is increased by decreasing Nai (by stimulating Na, K-ATPase using phenytoin, isoproterenol). Phenytoin and isoproterenol stimulate secretion and this can be blocked by agents which increase Cai Depolarization of the membrane (with high K) inhibits secretion in a Ca-dependent manner; the effect is blocked by D-600, a specific Ca-antagonist. Other Ca-antagonists are being studied, and their interaction with Cae. Peptides such as angiotensin II and antidiuretic hormone inhibit secretion in a Ca-dependent manner. The possibility that they act by depolarization, is being assessed by trying to block the effects with Ca-antagonists. The findings fit the hypothesis that Ca plays an inhibitory coupling role in renin secretion.